Strategies for next-generation flavivirus vaccine development

Dengue virus (DENV; DV) is the most common mosquito-borne virus in the world, with 4 billion people living in
regions that put them at risk for infection by any of its four serotypes (DV1-4). Infection by DV and its related
flavivirus Zika virus (ZIKV; ZV) may clinically manifest as mild flu-like symptoms, rash, and arthralgia. Severe
DV cases can progress into hemorrhagic fever and shock syndrome, while severe complications of ZV infection
include Guillain-Barre syndrome in adults and neonatal microcephaly. Severe dengue is associated with
antibody-dependent enhancement (ADE) of infection, a phenomenon seen as potentially fatal. In response to a
primary DV infection, the immune system produces antibodies that can bind and neutralize that serotype to
resolve infection. However, during a subsequent infection by a heterotypic DV serotype or ZV, some antibodies
from the primary infection are re-elicited but may poorly neutralize the heterotypic infection; thus, instead of
eliminating infection, these antibodies promote uptake of active virus into Fcγ receptor-expressing immune cells
and increase viremia and levels of pro-inflammatory cytokines. Currently, there is a need for vaccines and anti-
viral therapies for DV and ZV that do not carry the risk of inducing ADE. To avoid ADE, a significant goal for DV
and ZV vaccine development is to elicit broadly protective antibodies, as opposed to broadly reactive, non-
neutralizing ones. We determined two glycoproteins expressed by DV and ZV as favorable candidates for
immunogen design. Neutralizing, protective antibodies against DV and ZV have shown to target domain III (DIII)
of E glycoprotein, which is critical for viral entry and cell attachment. However, non-neutralizing, ADE-inducing
antibodies were also identified to bind to other motifs on WT DIII. Targeting WT NS1 glycoprotein, which plays
a key role in viral replication and endothelial dysfunction, may reduce disease severity without ADE, but it may
elicit non-neutralizing, even autoreactive antibodies. To address these challenges, structure-based approaches
may be used for immunogen mutagenesis and multivalent display of these immunogens. This proposal will
investigate methods to increase the immunodominance of heterologous epitopes found on the lateral ridge (LR)
of DIII and the β-ladder of NS1, while masking certain epitopes on these immunogens, to induce broad humoral
protection and mitigate severity of disease. We previously demonstrated the strong immunoprotecting potential
of a homotypic ZV immunization strategy, which involved the multivalent display of a LR-focused DIII mutant
onto nanoparticles. We will study the effectiveness of various heterotypic nanoparticles as cross-immunization
strategies against ZV and DV and characterize underlying humoral responses to the immunizations in mice (Aim
1). We will then explore the design of miniβ, a novel NS1 mutant which may be employed to curb disease
progression without eliciting ADE or autoreactive antibodies (Aim 2). These studies will further our understanding
of the adaptive immune response to flavivirus infections and may provide a framework for developing novel
vaccines and antibody-based therapeutics.

Public health relevance
Project Narrative Dengue and Zika viruses are mosquito-transmitted flaviviruses that cause severe, fatal disease in patients with history of previous infection by these viruses. Despite the growing population of at-risk communities because of globalization and climate change, there is still a need for vaccines and anti-viral therapies without the complication of enhancing disease severity. To address this need, we aim to engineer subunit vaccines effective against both viruses using techniques to focus the adaptive immune system to neutralizing, protective antibody response.